VITAMIN A STATUS IN CHILDREN WITH CHRONIC CHOLESTATIC LIVER DISEASE

The goal of this study is to test the feasibility and accuracy of noninvasive tests to assess vitamin A status in children with chronic cholestatic liver disease. We will also determine the frequency of vitamin A deficiency in a group of cholestatic children.